Pro-Type 2 Goblet Cell Antigen Passages in Food Sensitization and Reactivity

Project Summary
The U.S. Center for Disease Control and Prevention estimates of up to 6 million American children with
food allergies (roughly 2 in every classroom) at an economic cost of ~$25 billion per year. Currently, there are
limited FDA-approved treatment options for food allergy, with food avoidance remaining the only safe option. A
better understanding of the immune mechanisms and signaling pathways underlying food allergy is clearly
warranted to permit development of new effective and safe therapies8.
Over the last funded period our team identified “canonical” goblet cell antigen passages (GAPs) that act
to deliver dietary antigens to discrete immunological niches and imprint antigen presenting cells (APCs) with
tolerogenic properties to promote immune tolerance. Furthermore, we showed that the food allergic condition
was associated with altered gut antigen passage patterning and landscape. These IL-13/IL-4R-dependent
“non-canonical” antigen passages were required for induction of IgE-MC reactions.
In preliminary studies we demonstrate that systemic activation of the IL-13/IL-4R-signaling pathway is
sufficient to promote the outgrowth of SI pro-type-2 GC subpopulation, which express genes associated with
dietary antigen recognition and a distinct pro-type-2 inflammatory phenotype and form antigen passages.
Strikingly, we provide a link between disruption of skin barrier and pro-Type 2 cytokine production with increased
gut IL-13-producing ILC2 cells and a shift in gastrointestinal antigen passage landscape from the “canonical” to
“non-canonical” antigen passages. The current gap in knowledge is the requirement of pro-type-2 GCs to food
allergen passage and directing the allergic inflammatory response to the gut (allergic gut tropism) and priming
for food reactivity.
We hypothesize that SI pro-type 2 GCs act as non-canonical antigen passages, drive allergic gut tropism
and clinical reactivity to foods. To test our hypothesis, we propose three specific Aims (SA); SA1) Define the role
of systemic Type-2 signals in GI pro-type 2 GC-antigen passage formation; SA2) Define the role of GI pro-type
2 GC antigen passages in allergic gut tropism and SA3) Define the requirement of GI pro-type 2 GC antigen
passage-induced allergic gut tropism in food reactivity. With respect to the expected outcomes, the studies
proposed in SA1 are expected to demonstrate GI pro-type 2 GC antigen passages; SA2 demonstrate that GI
pro-type 2 GCs direct antigens to sensitizing LP-DC populations and recruit the food antigen-specific CD4+ Th2
cell response to GI tract and SA3) identify the requirement for GI pro-type 2 GCs in allergic gut tropism and
clinical reactivity.
Successfully completing the proposed studies will provide a new and substantive departure from our
current understanding of the underlying molecular mechanisms of dietary food allergen passage across the
intestinal epithelium underpinning a critical role for GI pro-type 2 GCs in allergic gut tropism and food reactivity
and warrant therapeutic targeting of pro-type 2 GCs for prevention of food allergic reactions.

Public health relevance
Food allergy is rapidly increasing in prevalence affecting up to 6 million American children at an economic cost of ~$25 billion per year. Currently there is an FDA-approved treatment for peanut allergy, however there are no approved treatments for other food allergies (shellfish, milk, tree nuts, egg, wheat, soy and sesame) which affect ~23.2 million Americans. Successful completion of the proposed studies will identify key cellular and molecular processes in the passage of dietary antigens to the gastrointestinal compartment and the priming for clinical reactivity to foods, thereby directing development of new and pre-existing therapeutics for treating all food allergies.